REDS-IV-P DATA COORDINATING CENTER - SARS-CoV-2/COVID-19 STUDIES

To evaluate and improve the safety and availability of the blood supply and the safety and effectiveness of transfusion therapies. The program also works to proactively address potential emerging threats to the Nation's blood supply and serves as a resource for ongoing work in transfusion research.